Research Resource for Human Organs and Tissues (U42)

Program Director/Principal Investigator (Last, First, Middle): Bell, Thomas, J.
PROJECT TITLE: HTORR/ NIAID High Priority HIV Human Biospecimen Recovery Program
PROJECT SUMMARY
The development of effective treatments or cures for a wide range of diseases requires translational studies that
are directly relevant to human pathophysiology. The use of human biospecimens plays a key role in accelerating
scientific discoveries in HIV research by providing scientists with a direct experimental model system to advance
understanding of HIV prevention, cure, co-morbidities, and therapeutic strategies. To address several complex
issues facing HIV research, including viral persistence, latency and reactivation as well as optimizing
preservation methods for human tissues, investigators require access to a unique resource that could provide
rigorous and uniform collection of human biospecimens from defined cohorts of HIV positive donors to yield
consistent and reproducible experimental results for inventive and groundbreaking studies. As a leading human
tissue provider for the biomedical research community, the National Disease Research Interchange (NDRI) is a
501(c)(3), not-for-profit organization that remains at the forefront of coordinating biospecimen procurement to
match the needs of advancing scientific experimental methodologies, enabling cutting-edge research. For over
30 years, NDRI has received NIH funding for the parent award to this administrative supplement, the Human
Tissue and Organs for Research Resource (HTORR) U42 Grant Number: U42OD011158. To address larger
scale and more complex projects in the field of HIV research that are beyond the scope of HTORR, NDRI is
expanding its capabilities for the biospecimen collection to align with broader unmet or under represented needs
in the field of HIV research. Our current Program Year (PY) 2 efforts include providing rigorous, large scale,
uniform collection of human biospecimens from highly defined cohorts of HIV+ donors to optimize tissue
preservation methods for HIV studies and to study viral persistence, latency and reactivation. The goal of our
PY3 proposal is to continue developing and implementing a large-scale biospecimen collection program to
provide ongoing support for high priority HIV studies for NIAID. To accomplish this goal, NDRI will: 1) lead the
development of large scale (>120 aliquots per donor) and complex (~30 tissue types per donor) recovery
projects, 2) identify and authorize HIV+ donors from both NDRI’s TSS and NIAID’s HIV+ donor referrals, 3)
collect relevant HIV+ donor data, 4) coordinate standardized biospecimen procurement, processing, and
preservation, and 5) distribute all biospecimens to Dr. Lane’s laboratory. In doing so, the biospecimen collection
and preservation methods will be optimized to support the generation of high-quality, reproducible data for
scientific review and publication.
RELEVANCE
Improving treatment for HIV infected patients or finding a cure requires access to high-quality human
biospecimens that are suitable for analysis using the most challenging experimental techniques. This approach
provides scientists with a direct experimental model system to advance understanding of HIV prevention, cure,
co-morbidities, and therapeutic strategies. The overall objective of our Program Year 3 proposal is to continue
developing and implementing a highly specialized, ongoing human biospecimen collection program for NIAID’s
HIV research initiatives.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Bell, Thomas, J. PROJECT TITLE: HTORR/ NIAID High Priority HIV Human Biospecimen Recovery Program Project Narrative: The research demand for human biospecimens continues to grow and the NIH-funded Human Tissues and Organs for Research Resource (HTORR) provides a unique service to biomedical investigators whose research requires access to normal and diseased biospecimens. Through continued generous support of the National Institute of Allergy and Infectious Diseases (NIAID), the capacity and capability of HTORR has been expanded to allow for large scale collection and distribution of human biospecimens to support the advancement of more complex projects with NIAID investigators. This established program is the called the HTORR/ NIAID High Priority HIV Human Biospecimen Recovery Program. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page